Advancing Diagnostics of Infectious Uveitis with MetagenomicAnalysis

PROJECT SUMMARY
Uveitis is a sight-threatening intraocular inflammation that affects young working-age individuals, resulting in
significant socioeconomic impacts. It is most often caused by infections or immune-mediated diseases. While
herpesviruses and Toxoplasma gondii are the leading causes of infectious uveitis, many other infectious agents
can be also involved, including viruses, bacteria, fungi and parasites. Clinical diagnosis is often complicated by
overlapping findings upon examination among cases caused by different infectious etiologies, and also with
observations made for those caused by autoimmune diseases and trauma. Because of that, complementary
laboratory tests are essential for the etiological diagnosis and proper clinical management. The laboratory
workup relies on multiple immunological tests and pathogen-targeted singleplex polymerase chain reaction
(PCR) assays. This approach increases significantly the time to diagnosis, is often prohibitive due to the limited
amount of intraocular fluid that can be safely obtained, and in many cases is unrevealing. As a result, patients
can be treated for weeks or months using one-size-fits-all therapeutic trials that are not tailored for an individual
and do not work for everyone. The use of metagenomic next-generation sequencing (mNGS) for unbiased
detection of every pathogen in a clinical specimen is an emerging diagnostic modality that has the potential to
significantly improve diagnostic yields in infectious uveitis. To date, there is a lack of an approach in which the
appropriate steps for analytical and clinical validations are thoroughly performed for the unique intraocular fluid
matrices tested from uveitic eyes. The studies proposed here are intended to fill this void and take on the
challenge of developing and systematically validating an unbiased mNGS test that can be translated into clinical
application for uveitis diagnosis and identification of new etiologies that currently escape diagnosis. First, we will
thoroughly establish the analytical performance characteristics of a mNGS test for detection of uveitis pathogens
from vitreous specimens. This will be done by using control vitreous containing varying levels of host DNA
background spiked with a reference pathogen panel that will be used to model the effects of important
determinants of analytical performance. Then, we will challenge this optimized mNGS assay with patient
specimens for determination of relevant clinical performance characteristics to fully validate this test for clinical
use. Using a combination of specimens stored in our biorepository and additional ones that will be collected
prospectively for a blinded challenge study, we will determine the diagnostic accuracy of the assay using different
sample types (e.g., aqueous vs. vitreous), its quantification capabilities, and will define clinical thresholds for
reporting of detected pathogens. This proposal will result in the development of a systematically validated and
innovative all-in-one diagnostic assay for infectious uveitis that is expected to substantially improve diagnostic
yields and help to illuminate novel infectious uveitis etiologies in cases that remain undiagnosed, with great
potential to for significantly changing the management of patients suffering from this debilitating disease.

Public health relevance
PROJECT NARRATIVE Uveitis is a sight-threatening intraocular disease that affects young working-age individuals, and is caused by a myriad of different etiologies that can present with overlapping features, resulting in a complex and difficult diagnostic process. The proposed project explores the enormous advantages of metagenomic next generation sequencing to develop a thoroughly validated approach for sensitive, unbiased and comprehensive detection of known uveitis-causing pathogens, which could additionally shed some light into novel etiologies of uveitis in the large number of cases that remain negative after extensive laboratory workup. We hope this work will ultimately provide an unparalleled all-in-one diagnostic assay validated for clinical application that translates into improved care for patients suffering from this debilitating disease.